Effects of Changes in Labor and Delivery Nursing Organizational Characteristics on Obstetric Outcomes and Disparities

Effects of Changes in Labor and Delivery Nursing Organizational Characteristics on Obstetric
Outcomes and Disparities
The rising rates of maternal morbidity and mortality in the United States demand answers. Childbirth is the
most common reason for hospital care, comprising 1 in 9 hospitalizations. Maternal morbidities, including
postpartum hemorrhage and peripartum infection, are principal determinants of maternal mortality. Cesarean
delivery in low-risk women is associated with significantly higher maternal and infant morbidity. These three
outcomes vary widely across hospitals and are marked by stark disparities between Black and non-Black
women. There is a compelling need to examine factors in the health care system that account for these
variations and disparities. Labor and delivery registered nurses are frontline care providers responsible for
monitoring and early recognition of and intervention for the prevention of these outcomes. They provide
continuous bedside care that is critical to achieving optimal birth outcomes. Evaluating the influence of nursing
on obstetric outcomes, however, has been largely ignored. In other hospital populations, patient outcome
variation has been linked to variation in nursing organizational characteristics, such as the nurse work
environment, nurse workload, and the percentage of Bachelor of Science in Nursing (BSN) degree-prepared
registered nurses. The clear clinical basis for nursing organizational characteristics to influence
obstetric outcomes and disparities creates a critical need to investigate these relationships to inform
professional guidelines and nursing unit organization to transform practice. We propose a novel,
geographically representative, multi-hospital cross-sectional and longitudinal study. We will determine whether
cross-sectional differences in nursing organizational characteristics (work environment, workload, BSN
percentage), relate to differences in three obstetric outcomes and disparities in outcomes in 867 hospital
observations from 2005, 2015, 2019, or 2023 in 26 states (Aim 1). We will study how longitudinal changes
across time points, including “post”-pandemic, in nursing organizational characteristics influence changes in
the three outcomes and disparities in these outcomes in a panel of 173 hospitals in 19 states (Aim 2). The Aim
2 panel comprises 309,670 deliveries per year. The study will capitalize on the availability of four national data
sets, comprising nurse survey (National Database of Nursing Quality Indicators, RN4CAST) and patient data
(Healthcare Cost and Utilization Project State Inpatient Data, state patient discharge data). This study
addresses the NINR mission: “To solve pressing health challenges and inform practice and policy—optimizing
health and advancing health equity into the future.” Our longitudinal and cross-sectional approaches along with
broad geographic representation will provide actionable evidence for hospital administrators and professional
groups.

Public health relevance
Project Narrative The rising rates of maternal morbidity and mortality in the United States demand answers. The obstetric outcomes of hemorrhage and infection, which contribute to maternal mortality, and cesarean delivery in low- risk women, which increases maternal and neonatal morbidity risk, vary widely across hospitals and are marked by stark disparities between Black and non-Black women. The overarching goal of the proposed research is to improve maternal health and reduce maternal health disparities by developing actionable evidence about the influence of changes in labor and delivery nursing unit organizational characteristics (work environment, nurse workload, percentage of registered nurses with a Bachelor of Science in Nursing degree) on these three obstetric outcomes and disparities in these outcomes.